Metaboloepigenetics and Atherosclerosis

PROJECT SUMMARY/ABSTRACT
Atherosclerosis-related cardiovascular diseases (CVD) remain the leading cause of death worldwide. Current
therapies mainly focus on managing the risk of atherosclerosis, rather than directly targeting the plaque-
causing cells. However, these treatments still carry a significant residual risk for CVD, along with various side
effects. Epigenetics and metabolism often occur early in various diseases and their close interaction has led to
the emergence of the concept of “metaboloepigenetics”. Yet, the precise mechanisms by which they respond
to environmental cues and contribute to chromatin modifications in atherosclerosis remains unaddressed.
Global changes in the epigenome are driven in part by the SWItch/Sucrose Non-Fermentable (SWI/SNF)
chromatin remodeling complex. This complex utilize the ATP energy to alter chromatin structure and modulate
chromatin accessibility to various molecular players, such as transcriptional machinery, cofactors. The mutually
exclusive BAF60 subunits serve as a link between the SWI/SNF complex and specific transcription factors. We
have demonstrated that BAF60c is essential for preservation of vascular smooth muscle cells (VSMC)
contractile phenotype by strengthening serum response factor (SRF) association with its coactivator P300 and
the SWI/SNF complex. Our preliminary data further show that BAF60c is the most abundant BAF60 family
member specifically expressed in VSMC in the normal arterial wall, and its expression decreases in human
and mouse atherosclerotic lesions. Furthermore, BAF60c deficiency in VSMC aggravates atherosclerosis in
mice. Knockdown of BAF60c leads to disturbed PPARγ activation and VSMC dysfunction, characteried by
increased anaerobic glycolysis, oxidative stress, lipid accumulation, transition to macrophage-like cells and
foam cells. Therefore, I hypothesized that BAF60c-PPARγ axis protects against atherogenesis through
metaboloepigenetic modulation of VSMC homeostasis. Our long-term objectives are to elucidate how
metabolo-epigenetic interplay modulates vascular cell behavior and fate in CVD and to uncover novel
therapeutic avenues for CVD by targeting BAF60c-dependent metaboloepigenetic modifications. Specifically,
Aim 1 will define the protective role of BAF60c-PPARγ axis in atherogenesis using both male and female
VSMC-specific knockout and transgenic mice; Aim 2 will define the mechanisms underlying BAF60c-PPARγ
axis in regulation of VSMC dysfunction in atherosclerosis in vitro. In summary, these studies will provide
unique mechanistic insights into the role of Baf60c-dependent metaboloepigenetics in VSMC homeostasis
during atherosclerosis. They will pave the way for further exploration of metaboloepigenetics in CVD. In
addition, these findings will support future endeavors to target BAF60c-dependent metaboloepigenetics and to
combine metabolism inhibitors and epigenetic modulators as potential therapeutic strategies for CVD.

Public health relevance
PROJECT NARRATIVE Atherosclerosis-related cardiovascular diseases remain the leading cause of death in the US. We propose to define the protective roles and underlying mechanism of BAF60c-dependent metaboloepigenetic modulations in atherosclerosis. This will provide unique mechanistic insights on the metaboloepigenetic mechanism of atherogenesis and will set the basis to explore new targets for treatment.